Intellectual and Developmental Disabilities Research Center

The University of Washington (UW) Eunice Kennedy Shriver Intellectual and Developmental
Disabilities Research Center (IDDRC), based at the Institute on Human Development and Disability
(IHDD), provides a comprehensive interdisciplinary program of basic and translational research
designed to prevent, diagnose, and treat individuals with intellectual and developmental
disabilities (IDD). Research is carried out within the framework of the following eight Collaborative
Research Areas (CRAs): (1) Biological Basis of Autism; (2) Brain Malformation Disorders; (3) Central
Nervous System Injury; (4) Consortium on Early Childhood Intervention; (5) Developmental
Toxicology; (6) Epilepsy; (7) Hearing Disorders, and (8) Learning Disabilities. All CRAs are
interdisciplinary, include scientists, clinicians, and trainees and are designed to promote
translational research. In this application, to facilitate the work of investigators at our IDDRC, we
are requesting support for an Administrative Core designed to provide scientific and programmatic
leadership and four scientific cores: (1) Genetics -- functional and human genomics and model
system components; (2) Brain Imaging – in vivo imaging for human studies and animal models; (3)
Animal Behavior – behavioral testing for rodent models and consultation for non-human primate
models and application of circuit mapping techniques; and (4) Clinical Translational -- promotes
and supports clinical and translational research. We are also proposing to conduct a research
project focusing on a unique cerebellar malformation utilizing comprehensive omic approaches
that are well integrated with cores and other IDDRC activities. Extensive research training and
dissemination activities are also integral components of our IDDRC.

Public health relevance
We are proposing to support investigators engaged in our research projects focusing on high priority areas in the ﬁeld of IDD conducted within an overarching framework of translational research. Combining the expertise of committed and well-established IDD investigators at the University of Washington with core and related University of Washington resources places our IDDRC in a position to make important advances in understanding the underlying causes of and providing effective treatments for individuals with IDD.